Circular RNA regulators of common drug-eliminating genes

Children signify a population with highly dynamic physiology and pharmacology at increased vulnerability to
drug toxicities. Biotransformation genes, commonly referred to as drug metabolizing enzymes and
transporters, have both pharmacological and toxicological significance. We have shown a robust postnatal
surge in hepatic expression of all biotransformation genes tested. In striking contrast, these very genes did not
show such surge in the duodenum, another major biotransformation organ. Interestingly, CYP3A4 mRNA
(cytochrome P450) decreased with age but CYP3A4 protein increased in the duodenum. Circular RNAs
(circRNAs) are emerging regulators and implicated to increase protein production by functioning as microRNA
sponges. As described in the Preliminary Study, we have shown the presence of circRNAs for CES1
(carboxylesterase-1), CES2, CYP3A4, and PXR (pregnane x receptor, a master regulator of biotransformation
genes). Their expression patterns varied between the liver and duodenum as well as age. The central
hypothesis of the proposed project is that circRNAs regulate the expression of biotransformation and related
genes in an age and organ-dependent manner. The Specific Aims are: (1) to characterize sequences and
functionality of circRNAs for biotransformation genes, and (2) to specify molecular actions of the circRNAs for
regulatory activities. To specify the functionality of circRNAs, the authenticity of detected circRNAs will be
sequence-confirmed, their organ/age-specific expression will be determined; and their regulatory activities
toward their parent and related genes will be specified. To ascertain the molecular action for the regulatory
activity, a circRNA will be tested for altered transcription rate, decay of mRNA, translational efficiency and
protein stability of a target gene. The circRNA-miRNA-mRNA network, known to support the sponging
mechanism, will be constructed bioinformatically for different organs. The scientific premise is strong and
original. The originality stems from the novelty of circRNAs as critical regulators of biotransformation genes
and the dependence of their regulatory activity on age and an organ. circRNAs have been increasingly
recognized to exert critical pathophysiological functions, however, their presence and functionality for
biotransformation genes remain largely unknown. These studies will have filled knowledge gaps on how
circRNAs participate in regulating biotransformation genes, critical determinants in drug efficacy and safety.
Clearly, information collected will serve a strong foundation for a bigger project.

Public health relevance
Project Narrative Children signify a population with highly dynamic physiology and pharmacology at increased vulnerability to drug toxicities. This project will specify molecular mechanisms whereby the defensive capacities are evolved during the early stage of life and how the defensive capacities can be enhanced for therapeutic advantage. Therefore, results from this project will have direct relevance to human health. .